Core--Cancer prevention and control

The purpose and objectives of the Cancer Prevention and Control (CPC) Core are to efficiently conduct translational studies of biomarkers for the detection of early cancer or high-risk exposure, trials of chemopreventive and high-risk behavioral interventions, and epidemiologic studies on cancer prevention and control. The CPC infrastructure comprises two components: (1) tissue repository and database core and the (2) minority outreach and recruitment core.